Cross-Ancestry Comparison of Aptamer and Antibody Proteomics Measures

PROJECT SUMMARY
Cardiovascular disease (CVD) is the leading cause of death in the United States, yet drivers of disease and
risk markers remain poorly characterized. Although CVD is more prevalent among non-Hispanic Blacks and
Hispanics compared to non-Hispanic Whites, these populations are underrepresented in existing genetic and
epidemiological studies of disease. New affinity-based high-throughput proteomics platforms offer
unprecedented opportunities to study disease mechanisms across diverse populations, and to search for new
clinical biomarkers of disease. However, initial comparisons of the leading proteomics platforms suggest that at
least one-third of protein measures correlate poorly between platforms, resulting in platform-specific or
platform-discordant genetic and epidemiological associations, which may confound biological interpretation of
results across studies. Genetic variants associated with circulating protein abundance measures may highlight
assays with on-target affinity-probe binding, as well as assays which may be non-specific or prone to
interference from protein-altering variants, which may affect affinity-probe binding and thereby alter protein
measure. As frequencies of these protein-altering variants may vary between populations, they may drive
differences in assay performance across populations. Here, we propose the first examination of protein
measure agreement in diverse populations, using newly generated affinity-based proteomics data across four
large studies of participants within the Trans-Omics for Precision Medicine (TOPMed) consortium. After
quantifying the correlation of protein measures for each platform within each study, and the heterogeneity of
these correlations between ancestral populations, I will identify technical and biological predictors of platform
correlation. Next, I will analyze whole genome sequences for contributing individuals to identify genetic
predictors of circulating protein abundances, as measured by each platform. I will characterize signals across
platforms to identify protein-altering genetic variants which may drive assay interference, and synthesize these
genetic associations with platform correlation coefficients to predict assay efficacy. Finally, I will model protein
measures from each platform against relevant cardiometabolic phenotypes to evaluate agreement of
epidemiological associations across platforms, and explore whether adjustment for protein-altering genetic
variants in epidemiological models may improve the concordance of associations. The results of this analysis
will disentangle reproducible protein measures and association results from those likely reflecting genetically-
driven assay interference, within and across populations, and present new strategies to harmonize
downstream associations for the impacted proteins across platforms.

Public health relevance
PROJECT NARRATIVE Emerging studies of cardiovascular disease are using two new affinity-based high-throughput proteomics platforms (SomaScan and Olink) to study the biology of disease and search for new circulating protein biomarkers; however, it is unknown whether these novel assays yield concordant measures, both within and across diverse populations. Here, we will systematically assess the agreement of protein measures from each of these two proteomics platforms across diverse populations, and use genetic analyses to predict assay reliability. We will further assess reproducibility of protein associations with cardiometabolic phenotypes, and evaluate strategies to harmonize epidemiological association results across platforms.